Member Site Core

The Project Summary/Abstract has been addressed in the Overall Component per the RFA

Public health relevance
The Project Narrative has been addressed in the Overall Component per the RFA